IMmune-mediated Adverse drug Reactions In African HIV endemic setting (IMARI-SA study)

Project summary/abstract
South Africa has approximately 7 million persons with HIV and 300 000 new TB cases a
year, and disease treatment is complex, requiring prolonged multi-drug therapy. Cutaneous
IM-ADRs occur in ~20% of all HIV-infected patients, and treatment-limiting severe cutaneous
adverse drug reactions (SCAR) are both overrepresented and under-studied in Africa.
The primary scientific objective of this K43 is to develop a well-defined cohort
with specific clinical and immune phenotypes to define the genetic and mechanistic
basis of SCAR associated with treatment of high burden diseases such as HIV and its
co-morbidities including tuberculosis. The overall training objective of this K43 is to
obtain theoretical and technical skills in advanced laboratory immunology that will prepare
the PI to become a global leader in drug hypersensitivity science. Focal areas for mentorship
and training include: i) Ex vivo assays to define drug-specific responses from peripheral
blood ii) HLA-biology to identify risk allele(s), including cluster analysis, iii) Pharmaco-
kinetics and genomics of culprit drug exposure and metabolism, and iv) Single cell T-cell
receptor and RNA sequencing techniques, both bench and analysis components. Training
areas are linked to the three study aims. Aim 1 is to define the unique clinical and
immunological phenotypes of SCAR in HIV uninfected, HIV infected and TB patients with
HIV co-infection in South Africa. A total of 250 SCAR cases and 500 matched controls to
target drugs will be characterized using clinical tools, in vivo and drug provocation testing;
and ex vivo assays such as ELISpot and flow cytometry to identify drug-specific T-cell
responses. Aim 2 is to define pharmacogenomic risk factors in this cohort through high
resolution HLA-typing and advanced genetic and pharmacological analyses, In Aim 3, we
will investigate the hypothesis that a dominant or oligoclonal drug-specific T cell population
(CD3+) exists at the site of acute tissue damage of these SCARs. We will use single cell
TCR sequencing and RNAseq of activated and antigen driven CD8+ and/or CD4+ T cells
from the skin in acute and recovery phases of SCAR.
We will assemble a well-defined cohort of SCAR patients and controls and predict
that we will define critical aspects of the epidemiology, pharmacogenomic and mechanistic
basis of SCAR in high burden HIV and TB populations in Africa. This will have direct
translation to SCAR in diverse treatment settings and translate into new ways to optimize
treatment and prevention of SCAR in HIV-TB infected patients.

Public health relevance
Project Narrative Immune-mediated adverse drug reactions (IM-ADRs) are a major obstacle to treatment success in both TB and HIV and a cause of tremendous morbidity, management complexity and economic burden. IM-ADRs are 100-fold more common in persons with HIV/AIDs, and over-represented in Africa; however, the immune pathogenesis is poorly understood, especially in non-European and HIV-infected populations. This study will fill significant gaps in our understanding of IM-ADR, for drugs used to treat HIV and TB in African populations. !